Administrative Supplement for Probabilistic Deep Learning Cervical Lymph-Node Auto-Segmentation For Imaging-enhanced Evaluation of Extracapsular Extension Risk (PDL-CLASIFIER)

PROJECT SUMMARY/ABSTRACT
Facial data in medical imaging poses a unique challenge, especially in the treatment of head and neck
cancer. While these images are essential for planning and delivering radiation treatments, they also include
identifiable features that raise privacy concerns. Techniques to obscure or remove facial features—known as
facial de-identification or "defacing"—have been proposed to reduce the risk of patient re-identification.
However, these methods often interfere with critical anatomical details needed for precise cancer treatment,
particularly in radiotherapy. Currently, there is no clear standard for using these techniques in head and neck
cancer imaging, creating uncertainty about the best way to balance privacy with maintaining the usefulness of
these images.
This administrative supplement will evaluate how different facial de-identification methods affect the
quality of medical images used in cancer treatment. We will study how these methods impact important steps
in the radiotherapy process, such as identifying tumors and planning treatment. By comparing original images
with de-identified ones, we aim to identify which techniques preserve the most critical information while
ensuring patient privacy. This work will provide valuable insights into the trade-offs between privacy and the
usefulness of medical data, helping researchers and clinicians make more informed decisions.
In addition, the project will engage with patients, clinicians, researchers, and other experts to explore
their views on sharing medical images containing facial features. Through structured interviews, we will
investigate ethical concerns, practical challenges, and potential solutions for responsibly sharing these
sensitive datasets. This stakeholder-driven approach will highlight diverse perspectives and provide an
evidence base to guide future discussions on privacy and data-sharing practices.
This collaborative effort between Baylor College of Medicine and The University of Texas MD Anderson
Cancer Center directly aligns with the goals of the NIH and the NIDCR to address ethical and privacy concerns
in sharing medical data. By combining technical research with stakeholder engagement, our work will enhance
the ability to share high-quality imaging data responsibly. This will not only foster innovation in cancer
treatment but also ensure public trust, ultimately benefiting patients and advancing research.

Public health relevance
PROJECT NARRATIVE Facial data in head and neck cancer imaging poses significant privacy risks, hindering data sharing and AI development. This project systematically evaluates facial de-identification algorithms and engages stakeholders to balance privacy with utility, enabling ethical sharing of clinically relevant imaging datasets while preserving patient trust and fostering innovation in radiotherapy applications.